E-Box Accessibility in Myofibroblasts in Pulmonary Fibrosis

ABSTRACT
Idiopathic pulmonary fibrosis (IPF) is a progressive and devastating disorder characterized by scarring in the
lung, which leads to impaired gas exchange, respiratory failure, and death. The accumulation and
differentiation of fibroblasts to the contractile and highly synthetic myofibroblast is a central event in the
pathogenesis of pulmonary fibrosis. Single cell-RNA sequencing technologies have defined the transcriptomic
profiles of multiple populations of fibroblasts in IPF lungs with unprecedented granularity. Single cell RNA-Seq
cannot, however, define collectively how these genes in the “myofibroblast program” are regulated. For this
level of information, complementary “multiomic” techniques are needed. To begin to explain how
myofibroblasts in IPF are regulated, we have performed single nucleus assay for transposase-accessible
chromatin sequencing (snATAC-seq) of IPF lungs and have discovered that the E-Box motif (CAGATG) is the
most enriched in DARs in myofibroblasts compared to non-myogenic fibroblasts. And of the E-box transcription
factors, we have discovered that TWIST1 is the most favorably predicted to bind to these E-boxes. We have
previously published experimental evidence that TWIST1 is important in the pathogenesis of pulmonary
fibrosis. These observations lead us hypothesize that the myofibroblast program in pulmonary fibrosis is
regulated by two parallel and essential events: the accessibility of E-Box motifs and the expression of the E-
Box-binding transcription factors including TWIST1. To test this hypothesis, we propose three specific aims.
The first is to determine the “regulatory architecture” of open chromatin in myofibroblasts in IPF. We will
determine transcriptional activity of the differentially-accessible regions of open chromatin identified by our
ATAC-Seq data. We will employ massively-parallel reporter assays, a novel technique in fibroblast biology.
Second, we will determine how expression levels of the E-Box transcription factors regulate myofibroblast
differentiation. Third, we will develop E-box decoys as a mechanistic way to disrupt myofibroblast effector
functions. Herein, we present a new model where the significant enrichment of E-Box motifs in regions of open
chromatin and the up-regulation of E-box transcription factors represent the essential elements of a conserved
and critical regulatory hub in the myofibroblast program in IPF.

Public health relevance
PROJECT NARRATIVE Idiopathic Pulmonary Fibrosis (IPF) is a fatal scarring disease of the lung. We will test the hypothesis that the myofibroblast program in pulmonary fibrosis is regulated by two parallel and essential events: the accessibility of E-Box motifs and the expression of E-Box-binding transcription factors including TWIST1.